Hyperpolarization Assisted and Structure Based Screening of Protein-Ligand Interactions in Live Cells

Abstract
Protein-ligand interactions play a pivotal role in fundamental biological processes including cellular signaling
and regulation. Experimental screening for interactions with drug candidate compounds and fragments further
represents an indispensable step in drug discovery. Traditional methods for determining such interactions often
require highly purified proteins, which in particular are not always available in the case of membrane proteins.
The same limitations exist for the characterization of functional complexes formed by recruitment of multiple
constituents on a membrane or within a cell. Notwithstanding, 60% of current drugs target membrane proteins.
Here, a method will be developed for determining interactions between small molecules of arbitrary type,
directly with receptors or other components located on the surface or within a cell. Nuclear magnetic
resonance (NMR) signals of ligands will be enhanced by several orders of magnitude using dissolution
dynamic nuclear polarization (D-DNP). The non-equilibrium spin states produced by this hyperpolarization
technique results in sensitivity gains enabling detection to targets in the nanomolar concentration range. At the
same time, hyperpolarization provides contrast over complicated background spectra. It thus enables the label-
free, selective detection of the ligand of interest, while retaining the chemical information available in NMR
spectroscopy. In a first aim of the project, an experimental method for detecting and characterizing binding in
heterogeneous models containing proteins in lipid vesicles will be developed. Nuclear spin relaxation under
competitive binding, and intra- or interligand nuclear Overhauser effect (NOE) will provide binding affinity
measurements and structural constraints within the binding pocket. In a second aim, these methods will be
applied to characterize the binding of ligands to a G-protein coupled chemokine receptor on the surface of
mammalian cells. A dedicated device for NMR detection of cell cultures perfused with hyperpolarized media will
be developed for this purpose. A third aim will extend these methods to access targets within the cytosol or an
internal membrane of the cell, here specifically an oligomeric signaling protein from the cGAS-STING interferon
induction pathway. Hyperpolarized water will be naturally transported across the cell membrane.
Hyperpolarization will then transfer to intracellular components by proton exchange or NOE, resulting in
detectable signal changes of unlabeled or selectively isotope labeled ligands within the cell. Together, these
aims will provide a comprehensive, novel toolset to characterize protein-ligand interactions in the natural
environment of the cell.

Public health relevance
Project Narrative Transmembrane proteins among other functions are responsible for signal transmission between cells. A large fraction of drugs being currently marketed or developed target membrane standing receptors, including the G- protein coupled receptors. This project aims to develop a method that allows the identification of binding and determination of binding epitope structure of receptors in the natural environment in a cell, which would greatly facilitate the drug discovery process.